The role of somatostatin-expressing GABAergic interneurons in depressive behavior

Project Summary/Abstract Major Depressive Disorder (MDD) is a highly prevalent and debilitating psychiatric syndrome marked by depressed mood and lack of interest. Stress is an important risk factor for MDD and often precipitates depressive episodes. Current antidepressant drugs require several weeks of treatment to achieve therapeutic efficacy and most patients do not achieve remission with the first antidepressant prescribed. These limitations of current antidepressant drugs highlight the need for a better understanding of the pathophysiology of MDD and identification of novel therapeutic targets. Clinical evidence suggests that MDD is associated with reduced concentrations of the inhibitory neurotransmitter γ-aminobutyric acid (GABA) in certain brain regions and reduced expression of GABAA receptors (GABAARs). Somatostatin (SST), a neuropeptide marker of a major subset of primarily dendrite-targeting GABAergic interneurons, is also reduced in certain brain regions of depressed patients. Reducing GABAergic synaptic transmission in mice by heterozygously deleting the γ2 subunit of GABAARs results in an anxious-depressive-like phenotype that includes HPA axis hyperactivity and is normalized by treatment with currently used antidepressants as well as subanesthetic doses of ketamine. Given these findings, we predicted that disinhibition of SST-positive (SST+) GABAergic interneurons through deletion of the γ2 subunit of GABAARs selectively in these neurons (SSTCre:γ2f/f) would result in an antidepressant-like phenotype. Indeed, these mice show reduced depression-related behavior as well as reduced anxiety, along with enhanced GABAergic input to principal cells. Preliminary biochemical analyses of extracts from the hippocampus and medial prefrontal cortex (mPFC) of SSTCre:γ2f/f mice further show reduced phosphorylation of eukaryotic elongation factor 2 (eEF2), consistent with corresponding changes in eEF2 phosphorylation upon treatment of rodents with three different classes of antidepressant drugs and suggestive of enhanced dendritic translation. Based on these findings we hypothesize that enhanced protein translation, particularly in dendrites of principal cells in the hippocampus and mPFC, may underlie the phenotype of SSTCre:γ2f/f mice that mimics antidepressant drug treatment. The goal of this study is to determine whether SSTCre:γ2f/f mice are resilient to unpredictable chronic mild stress (UCMS)-induced depressive behavior and to investigate the molecular mechanism underlying their anxiolytic and antidepressant-like phenotype. To this end, we will cross SSTCre:γ2f/f mice and γ2f/f controls with a line of transgenic mice that express an epitope-tagged ribosomal subunit selectively in pyramidal cells of the hippocampus. This will allow us to isolate polysome-associated mRNAs from principal cells. RNAseq analysis of these mRNAs will then be used to identify transcripts that are differentially translated in SSTCre:γ2f/f versus γ2f/f mice, either at baseline or following UCMS, with the hope of identifying novel candidate protein targets suitable for antidepressant drug therapies.

Public health relevance
Project Narrative Major Depressive Disorder (MDD) is the most common psychiatric syndrome in the United States, but we still do not fully understand the underlying disease process and current therapies are ineffective in many patients. Reductions in the major inhibitory neurotransmitter in the brain, γ-aminobutyric acid (GABA), may play a role in the pathology of MDD and we have evidence that enhancing GABAergic transmission produces antidepressant-like consequences in mice. By studying the molecular pathways by which changes in GABA affect depressive behaviors, we hope to identify novel targets for antidepressant drugs.